Obesity and Adipose Tissue

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Obesity and Adipose Tissue, organized by
Drs. Paul Cohen, Ruth J.F. Loos, Claudio J. Villanueva and Christian Wolfrum, with scientific programming input
from Keystone Symposia. The meeting will take place February 23–26, 2025 at Fairmont Banff Springs, Banff,
Alberta, Canada.
Obesity is a major risk factor for type 2 diabetes, metabolic-associated fatty liver disease, cardiovascular disease,
and many types of cancer. Collectively, these associated diseases are the leading causes of morbidity and
mortality worldwide. This conference will highlight advances in the biology of adipose tissue and the
pathophysiology of obesity, which will be essential in addressing this major threat to human health. The
conference program will bring together researchers from academia and industry to focus on obesity and adipose
tissue. This meeting has been designed to encourage cross-disciplinary insights and collaborations towards
understanding underlying mechanisms of how obesity leads to liver disease. Accordingly, it has been paired with
another Keystone Symposia conference, MASH Pathogenesis and Therapeutic Approaches, to support new
collaborations geared toward understanding the important intersections of obesity and metabolic diseases.

Public health relevance
PROJECT NARRATIVE Obesity, which is defined as an excess of adipose tissue, represents one of the most serious threats to human health worldwide and is a major contributing factor to metabolic syndrome and associated diseases. However, remarkable therapeutic breakthroughs over the past few years have changed the landscape of obesity and cardiometabolic disease treatment. In pairing this meeting with another Keystone Symposia conference, MASH Pathogenesis and Therapeutic Approaches, the conference program will feature advances in adipocyte biology and highlight emerging therapies for obesity and related metabolic diseases, while also describing new therapeutic targets identified through both basic studies and by leveraging the power of human genetics.